Investigating the role of BAFF in CAR-T cell associated adverse events

PROJECT SUMMARY
Despite the impressive therapeutic success of chimeric antigen receptor (CAR)-T cell therapy in treating
previously incurable hematological malignancies, its use is associated with significant safety concerns. The most
common and potentially life-threatening adverse events (AEs) after CAR-T cell infusion are cytokine release
syndrome (CRS) and immune effector cell-associated neurotoxicity syndrome (ICANS). The incidence of high-
grade events makes up a quarter to a half of cases of patients who experience these toxicities. In addition to risk
to patient safety, management of these AEs increases health care resource utilization and financial burden. Both
events are associated with a heightened immune effector state following CAR-T cell infusion, yet their underlying
pathophysiology remains elusive. After infusion, the activated CAR-T cell repertoire stimulates recruited
macrophages to propagate a dysregulated pro-inflammatory state which can cause vascular leakage and CRS.
Progression into the central nervous system causes ICANS. IL-6 is a central mediator in this mechanism and its
neutralization with tocilizumab is standard of care for treating CRS. However, CRS may recur in some
tocilizumab-treated patients and, significantly, tocilizumab does not prevent progression to ICANS, which is
managed with glucocorticoids. Novel discoveries into the mechanisms of CRS and ICANS may uncover
treatment strategies that could more effectively manage both AEs. To this end, we are interested in studying a
novel role for B-cell activating factor (BAFF) in CRS/ICANS pathophysiology. BAFF is a TNF family cytokine that
drives B-cell maturation and survival and classically studied for its pro-tumorigenic effects in B-cell malignancies.
We recently found that serum BAFF levels are significantly elevated with increased IL-6 relative to pre-treatment
levels in patients who experienced CRS following CAR-T cell infusion. When exploring a potential role of BAFF
in CRS/ICANS pathophysiology, we found that interferon gamma (IFNγ) stimulates monocytes to secrete BAFF
and upregulates two receptors of BAFF. BAFF stimulation of peripheral blood mononuclear cells and, more
specifically, monocytes, results in increased expression of multiple pro-inflammatory cytokines involved in
CRS/ICANS pathophysiology. Conversely, neutralization of soluble BAFF with belimumab resulted in decreased
expression and production of these cytokines. Based on this preliminary data, we hypothesize that IFNγ released
from activated CAR-T cells stimulates recruited monocytes to increase BAFF production and expression of BAFF
receptors. BAFF ligation may be an early event that stimulates production of pro-inflammatory cytokines to
propagate the CRS and ICANS sequelae. Clinically, targeting BAFF may represent a promising therapeutic
approach to blunt the dysregulated proinflammatory cascade at an early stage and limit the development of both
AEs. Based on the pro-tumorigenic role of BAFF, this could concurrently help to limit disease burden. In summary,
discoveries made in this proposal will add mechanistic insight to the most common toxicities that accompany
CAR-T cell therapy and potentially lead to novel therapeutic approaches to make this life-saving therapy safer.

Public health relevance
Despite the major clinical success of chimeric antigen receptor (CAR)-T cell therapy in hematological malignancies, this therapy is accompanied by potentially life-threatening adverse events: cytokine release syndrome (CRS) and immune effector cell-associated neurotoxicity syndrome (ICANS). This proposal aims to investigate a novel role of B-cell activating factor (BAFF) in the pathophysiology of these adverse events. These findings will directly translate to the investigation of BAFF neutralization as a mechanism to limit the CRS and ICANS sequelae in patients following CAR-T cell infusion, which will ultimately result in safer life-saving therapy for these patients.